Replication fork repriming versus reversal

Summary: The objective of this proposal is to understand the mechanisms that govern DNA replication fork
stability upon treatment with multiple-­drug doses in BRCA-­mutant tumors. Mutations in the breast cancer
susceptibility genes BRCA1 and BRCA2 are associated with several forms of cancer, including breast and
ovarian cancers. BRCA proteins are required for the maintenance of replication fork stability following treatment
with chemotherapeutics such as cisplatin, a DNA cross-­liking agent widely used for cancer treatment. Replication
forks can reverse to aid the repair of DNA damage induced by chemotherapeutics and BRCA proteins are key
to protecting the reversed structures from nucleolytic degradation. In absence of BRCA, reversed replication
forks are extensively degraded by nucleases, leading to chemosensitivity. However, the molecular basis of the
DNA-­damaging drug sensitivity in BRCA-­mutant tumors remain unclear. Defining these mechanisms is crucial
for basic research to inform and improve current clinical oncology regimens based on DNA replication inhibitors.
Most studies focus on the analysis of replication perturbations following a single-­dose treatment. For the first
time, we investigated replication fork perturbations in BRCA1-­deficient cells treated with cisplatin 24 hours after
pre-­exposure to this drug. Our preliminary data challenge the dogma that DNA-­damaging drug sensitivity
originates from the extended replication fork degradation phenotype observed after a single-­dose treatment in
BRCA1-­deficient cells. We found that fork degradation is no longer detectable when using multiple cisplatin
doses. This effect depends on the overexpression and DNA primase activity of the PrimPol polymerase. Based
on this premise, we hypothesize that a PrimPol-­dependent pathway rescues replication fork degradation
following multiple rounds of cisplatin treatment and modulates cisplatin sensitivity in BRCA1-­deficient cells. We
also posit that cancer cell reliance on fork repriming is enhanced under any condition that leads to reversed fork
degradation¾e.g., BRCA1 or BRCA2 protein deficiency.
Aim 1 will define the function of the dual enzymatic activity of PrimPol in replication fork stability in BRCA1-­
deficient cells following treatment with multiple cisplatin doses. Aim 2 will determine whether PrimPol-­mediated
repriming rescues fork degradation by suppressing fork reversal, which would otherwise lead to extensive
nascent strand degradation in BRCA-­mutants. Aim 3 will determine the impact of the cisplatin-­induced PrimPol
overexpression on genomic instability and BRCA1-­deficent cancer cell viability. This will be achieved by using a
unique combination of single-­molecule DNA replication and electron microscopy approaches available in our
laboratory. These studies will establish a new paradigm for the PrimPol polymerase in replication fork protection
and genomic stability. They will also introduce the novel concept that multiple-­drug doses need to be used to
fully understand how cells respond to chemotherapeutics, and they will offer new insights for the treatment of
BRCA-­mutant cancer patients by targeting the PrimPol-­dependent pathway.

Public health relevance
Project Narrative: This project will address fundamental questions about a novel mechanism by which individuals with BRCA gene mutations maintain their genome. Specifically, we identified the PrimPol- dependent repriming pathway as a novel important regulator of genome stability and as a factor that might influence sensitivity to DNA damaging chemotherapy, particularly in BRCA- mutant tumors.